Circuit mechanisms underlying network disruption and temporal processing deficits in Alzheimer's

Abstract:
Despite substantial knowledge of the molecular and genetic mechanisms contributing to amyloid pathology,
very little is known about how these molecular mechanisms affect the operation of neural circuits, and how this
disrupts neural computation to ultimately produce behavioral deficits in Alzheimer's. Here we seek to
understand the mechanisms underlying two emerging early biomarkers — auditory gap detection deficits and
functional disconnection of cortical networks — and how these are mechanistically related to one another. The
objective of this proposal is to determine when and how network function is disrupted in auditory and other
cortical areas, and how this impairs behavioral gap detection in the 5XFAD mouse model of Alzheimer's. Our
central hypothesis is that gap detection deficits result from specific disruption of gap detection circuits in
auditory cortex, as a consequence of large-scale network disruption both within and among cortical areas. Aim
1 will determine the computational mechanisms underlying progressive network disruption. Our working
hypothesis is that network disruption is not just a global degradation, but occurs specifically as a loss of hub
neurons over time, disconnecting modules and cortical areas. Aim 2 will determine how network disruption
affects the flow of feedforward and feedback information across the cortical hierarchy. Our working hypothesis
is that top-down feedback projections are impaired earlier and more profoundly than feedforward projections.
Aim 3 will determine how network disruption impairs the computation of gap selectivity in auditory cortex, and
how this impairs gap detection behavior. Our working hypothesis is that gap selectivity is computed in the
superficial layers and impacts behavior via output from layer 5. We will test these hypotheses with a
combination of chronic mesoscopic 2-photon GCaMP8f imaging, high-density electrophysiology, and
quantitative behavior in 5XFAD mice. The proposed research is innovative because it uses novel
imaging/electrophysiology approaches to address how molecular pathology disrupts the operation of neural
circuits, and how this in turn disrupts neural computation to produce early-onset behavioral deficits. The
proposed research is significant because it will provide a detailed cellular- and synaptic-level mechanistic
explanation of the nature of large-scale network disruptions in Alzheimer's, and reveal how these disruptions
affect specific neural computations in auditory cortical circuits that produce specific behavioral deficits. This
understanding will deepen and extend the validity of both gap detection and fMRI functional connectivity
measures as early biomarkers for Alzheimer's, and provide insight into the nature of the window of opportunity
for potential therapeutic intervention during synaptic network impairment before permanent structural damage
occurs.

Public health relevance
Narrative: There is widespread consensus that early detection of Alzheimer's using non-invasive biomarkers is critical, because cognitive and memory deficits occur past the point of no return. Full validity and relevance of these biomarkers requires detailed understanding of their underlying biological mechanisms, and how they relate to disease progression. Here we seek to understand the cellular and circuit mechanisms underlying two emerging biomarkers, gap detection and fMRI functional connectivity measures. This understanding will deepen and extend the validity of these biomarkers for early diagnosis of Alzheimer's, could also provide a basis for the development of new therapeutic strategies.